Glutamatergic plasticity that drives cannabinoid withdrawal and craving

PROJECT SUMMARY/ABSTRACT
Cannabis is the most frequently used illicit drug in the United States. Onset of cannabis use usually occurs
during adolescence, which represents a vulnerable period in neurobiological development. Due to uncertainty
surrounding the long-term consequences of adolescent cannabis exposure, there is mounting concern that
relaxing legal restrictions will result in increased adolescent use. Approximately 30% of users develop
cannabis use disorder (CUD), and nearly half of all regular cannabis users develop cannabis withdrawal
syndrome which is marked by negative affective symptoms and craving that may drive relapse. During
abstinence craving may increase over time or “incubate” resulting in a period of heightened vulnerability to
relapse in response to drug-related cues. Withdrawal symptoms during abstinence are clinically significant
because they may impact efforts to reduce cannabis use, promote use of other substances of abuse, and
adversely influence treatment outcomes. Currently there are no approved pharmacotherapies for CUD. The
primary objective of this proposal is to determine how chronic cannabinoid use in adolescence impacts
glutamatergic transmission and plasticity in the nucleus accumbens (NAc), and the contribution of these
adaptations to later relapse-like behavior and craving. Our central hypothesis is that cannabinoid self-
administration and withdrawal induces changes in glutamate transmission and synaptic connectivity in the NAc
that promote negative affective processes and ultimately trigger relapse. To test this hypothesis we will use
behavior, whole mount immunohistochemistry and light sheet microscopy, optogenetic aided neurophysiology,
and chemogenetic manipulation techniques to assess the involvement of pathway specific glutamatergic
neuroplasticity in cannabis seeking. We will use a model of adolescent intravenous D9-tetrahydrocannabinol
(THC) self-administration and withdrawal to confirm the presence of an incubation of drug seeking effect at an
intermediate or protracted withdrawal time point. We will assess somatic and non-somatic symptoms of
spontaneous withdrawal based on alignment with DSM-5 criteria and the Research Domain Criteria framework.
Unbiased mapping of whole brain c-Fos immunoreactivity will be used to identify regional neural activation
associated with cannabinoid withdrawal and cue-reactivity. We will examine input-specific cannabinoid
withdrawal-induced plasticity at glutamatergic synapses in identified D1 and D2 medium spiny neurons in NAc
core and shell coupling in vitro slice electrophysiology with optogenetically evoked EPSCs. Finally, we will
utilize chemogenetic neuromodulation to test the importance of one of these circuits for regulating relapse-like
behavior and endophenotypes of withdrawal. These studies will inform our understanding of the mechanisms
underlying cannabis withdrawal syndrome, an important and understudied facet of CUD, and how glutamate
transmission and synaptic plasticity is altered over the course of withdrawal. This may have important
implications for identifying unique therapeutic targets.

Public health relevance
PROJECT NARRATIVE Initiation of cannabis use usually occurs during adolescence, which represents a vulnerable period in neurobiological development. The proposed research is designed to elucidate how chronic cannabinoid use during adolescence produces neural plasticity- that is changes in brain structure and function- related to short- and long-term behavioral adaptations exemplified by withdrawal and relapse-like behavior. Identifying these important adaptations may inform the development of novel therapies for cannabis use disorder.